The Mid-Atlantic Center for Cardiometabolic Health (MACCH)

ABSTRACT
The Mid-Atlantic Center for Cardiometabolic Health (MACCH)
The overarching goal of the Mid-Atlantic Center for Cardiometabolic Health (MACCH) is to test the effectiveness of comprehensive, integrated, and multi-level evidence-based strategies for improving cardiometabolic health outcomes among populations with unmet social and health needs in Maryland, using community- based participatory research and patient-centered outcomes research principles, and translate them into clinical and public health practice and policy. We will leverage the existing infrastructure of the JHCHE, which has applied a comprehensive approach to improve health outcomes for over 10 years, a partnership with the University of Maryland Baltimore, and collaborations with Morgan State University and other institutions in the region. MACCH will include 3 separate, but related intervention studies addressing cardiometabolic disease; 3 integrated cores (Administrative, Investigator Development, and Community Engagement); an Executive Committee; and a Community Advisory Board. Study 1 is a randomized trial comparing the effectiveness of an evidence-based pregnancy/postpartum health coaching/home visiting intervention to usual home visiting services in reducing postpartum weight retention among Black and Latina women with elevated risk for suboptimal cardiometabolic health outcomes; Study 2 is a randomized trial examining the effectiveness of a multi-level intervention of problem-solving training, community health worker (CHW) support and partnership with community facilities for enhancing cardiorespiratory fitness in adults with limited financial resources, diabetes, obesity and asymptomatic cardiac dysfunction; and Study 3 is a cluster- randomized trial testing the effectiveness of a multi-level intervention linking self-monitored blood pressure (BP) with telemonitoring, team-based care with pharmacists and CHWs, and provider-level interventions compared to enhanced usual care, for improving BP control among adult populations with unmet social and health needs with uncontrolled hypertension plus diabetes or chronic kidney disease. The Administrative Core will carry out the overall administration of the grant, providing infrastructure and support for data harmonization, management and analysis, patient recruitment and retention, and intervention adaptation and implementation. The Investigator Development Core will establish a pilot project program for early-stage investigators and create a mentoring network and community for pilot project awardees, to support innovative research related to chronic disease. The Community Engagement Core will implement a shared governance structure to reinforce stakeholder leadership and ownership; advance, facilitate, and evaluate MACCH’s community-engaged research and investigator development initiatives; and employ community-centered strategies to translate, disseminate, and sustain MACCH initiatives. The MACCH will advance the science of cardiometabolic disease and facilitate its translation into clinical and public health practice and policy.

Public health relevance
Public Health Relevance Section OVERALL PROJECT NARRATIVE The overarching goal of the Mid-Atlantic Center for Cardiometabolic Health (MACCH) is to test the effectiveness of comprehensive, integrated, and multi-level evidence-based strategies for improving cardiometabolic health outcomes among populations with unmet social and health needs in Maryland, USA. The MACCH will advance the science of cardiometabolic disease and facilitate its translation into clinical and public health practice and policy.